Molecular and Functional Mechanisms Underlying Cortical Activity in CACNA1A Epilepsy

PROJECT SUMMARY/ABSTRACT
The CACNA1A gene encodes the α1A subunit of the P/Q-type voltage-gated calcium channel Caᵥ2.1
which facilitates presynaptic neurotransmitter release in neurons. Loss-of-function (LOF) and gain-of-function
(GOF) variants in CACNA1A are both associated with developmental and treatment-resistant epileptic
encephalopathy in patients. How do variants with divergent effects on Caᵥ2.1-mediated calcium influx converge
to produce overlapping epileptic symptoms? Electrophysiology studies from mouse models have revealed LOF
variants selectively disrupt inhibitory neuronal function while GOF variants selectively affect excitatory
neurotransmission. We propose that cortical excitatory/inhibitory balance is disrupted in both cases, with LOF
leading to weakened inhibition and GOF leading to excessive excitation. Selective disruption of inhibitory
neurons in LOF and excitatory neurons in GOF have led to the hypothesis that cell types may functionally
compensate by upregulating other calcium channels in LOF while downregulating calcium channels in GOF.
However, molecular mechanisms underlying this compensation—including specific channels affected and the
degree to which they successfully rescue calcium influx and normal neuronal activity—appear species-specific
and cell type-specific. No published study has examined consequences of CACNA1A mutations on expression
of genes beyond other calcium channels. To bridge these gaps and improve our understanding of how cortical
hyperexcitability emerges in human CACNA1A-related epilepsy, I will characterize cell type-specific functional
activity and gene expression in CACNA1A mutations with a 3D, human-derived in vitro model of the developing
cortex. Utilizing forebrain assembloids containing cortical cell types from engineered LOF, GOF, and unedited
isogenic control lines, this proposal compares function and gene expression of excitatory and inhibitory
neurons between genotypes. Aim 1 utilizes calcium imaging to assess calcium transient rates and calcium
influx of excitatory and inhibitory neurons alongside network-level measures of excitability. Aim 2 employs
single-cell RNA sequencing to ask how gene expression of excitatory and inhibitory neurons is differentially
affected in LOF and GOF relative to controls. Together, these experiments may identify expression changes in
calcium channels and novel pathways in Aim 2 that explain cell type-specific functional abnormalities in LOF
versus GOF revealed in Aim 1. The central hypothesis is that excessive activity and insufficient downregulation
of calcium channels in excitatory neurons leads to hyperexcitable cortical networks in LOF while reduced
activity and insufficient upregulation of calcium channels in inhibitory neurons leads to hyperexcitable cortical
networks in GOF. Completion of these aims will provide novel insights into compensatory mechanisms,
functional abnormalities, and etiology of epileptic phenotypes in CACNA1A for the first time in a human-derived
model system—potentially informing novel therapeutic targets and variant classification criteria.

Public health relevance
PROJECT NARRATIVE CACNA1A mutations are an underdiagnosed cause of severe, treatment-resistant, early-onset epilepsy and other neurological disorders including familial hemiplegic migraine type 1, episodic ataxia type 2, and spinocerebellar ataxia type 6. This proposal will use the first human-derived, three- dimensional model system of CACNA1A to investigate effects of loss-of-function and gain-of-function mutations on functional activity and gene expression in excitatory and inhibitory cortical neurons. These experiments may reveal how excitation/inhibition imbalance—a common feature among genetic epilepsies and other neurodevelopmental disorders—emerges in developing cortical circuitry, paving a path for identifying novel therapeutic targets and variant classification criteria immediately relevant to the CACNA1A community.